Targeting mechanosignaling in pediatric brain cancer

Project Summary
Despite multimodal treatment, cancer-related mortality in pediatric brain cancers remains high and survivors
often suffer from serious, life-long, therapy-related side effects and secondary malignancies. There is a clear
need for more effective therapies, including for the most common malignant pediatric brain cancer medullo-
blastoma, a tumor that originates in the cerebellum. Mechanosensitive signaling pathways have emerged as
powerful targets in cancer drug discovery, including for the treatment of medulloblastoma. Yet, when targeting
signaling pathways that serve as sensors for a tumor cell's microenvironment, traditional monolayer cultures that
are most commonly used in cell-based high-throughput drug discovery, do not accurately recapitulate critical
environmental cues such as tissue stiffness or extracellular matrix composition. Drug discovery aimed at key
mediators of mechanosensitive signaling require cell-based screening assays in a cell culture environment that
more closely resembles in vivo tissue. Three-dimensional (3D) cell cultures have moved to the forefront in the
effort to create more in vivo-like experimental environments that can mimic intricate cell-cell and cell-extracellular
matrix interactions found in tissue. Our previous collaborative work demonstrated the suitability of the self-
assembling and hydrogelating MAX8 β-hairpin peptide as a 3D cell culture scaffold for automated high-
throughput drug discovery. We demonstrated that MAX8 combines biocompatibility and tunability in function and
stiffness with unique mechanical properties (e.g., shear-thinning, injectable solid with immediate rehealing) that
allow automatic handling with standard high-throughput screening (HTS) liquid handling equipment commonly
found in a drug discovery laboratory. The primary objective of this proposal is to use the versatile and tunable
MAX8 peptide to develop a 3D cell culture scaffold that mimics key features of brain extracellular matrix while
also retaining material properties critical for use with automated liquid handling equipment, all for a high-
throughput drug discovery approach targeting mechanosignaling. Aim 1 will establish a targeted assay for a well-
characterized mechanosensitive signaling pathway that is compatible with MAX8 peptide hydrogel scaffold-
based 3D cell cultures in a high throughput-compatible setup. Aim 2 will examine how tuning hydrogel stiffness
and peptide functionalization with brain extracellular matrix components affects assay performance and
phenotype of cerebellar neurons and pediatric brain cancer cells. Aim 3 will validate the newly developed assay
platform by performing a pilot drug screen and in vivo efficacy testing of candidate compounds. The outcome of
these studies will be a 3D cell culture platform that will provide fundamental understanding of how extracellular
matrix composition and tissue stiffness regulate mechanosignaling in both normal neurons and pediatric brain
cancer cells. Additionally, these studies will lay the foundation for a future high-throughput drug discovery
approach targeting mechanosignaling in scaffold-based 3D cultures optimized for pediatric brain tumors.

Public health relevance
Project Narrative Public Health Relevance In comparison to many other childhood cancers, the prognosis of pediatric brain cancers remains poor. Targeting pathways that relate information from the tumor microenvironment and serve as intracellular regulatory hubs presents new opportunities for developing innovative therapeutic approaches, including in pediatric brain tumors. The proposed research will develop a tunable three-dimensional cell culture platform that is compatible with automated high- throughput screening for targeting an oncogenic signaling pathway that serves as a central integrator of information from the tumor microenvironment.